Studies of the function of membrane and soluble proteins and their biophysical properties.

Project Summary from the Parent Award
Over the past 50 years, the field of biophysical chemistry has learned an enormous amount about the
relationships between the function, dynamics and folding of soluble proteins. The next stage in biological science
involves addressing more complex problems on more challenging systems using increasingly sophisticated
approaches augmented by computational methods. The Sosnick lab has followed this path. We are conducting
studies of membrane proteins, condensates and disordered proteins. Our ability to address these topics arises
in part from our expertise in the folding of soluble and more recently, membrane proteins. We build on this
experience and knowledge to advance new or improve existing methods. The proposed research relies heavily
on hydrogen exchange (HX), a method developed to study folding and dynamics yet possessing broad
transferability to many methods. We plan to continue this approach and study the voltage activation of a sensory
motor protein, metabolite transport across a bilayer, stress-induced phase separation, and properties of
disordered proteins in addition to membrane protein folding. To address these topics in depth, we are expanding
HX's applicability to membrane proteins under an activating voltage, during their folding, and even in vivo to
examine their dynamics in cells. These studies are augmented by simulations conducted with our Upside
algorithm that is 103-104 fold faster than ordinary simulations. This speed enables Upside to produce HX patterns
that can be compared to experiment. Many of the projects are collaborative, leveraging our skills and interests
with those of other labs, which further supports the value of our studies.

Public health relevance
Project Narrative from the Parent Award Through the application of advanced biophysical methods and computational approaches, we will address a range of exciting yet challenging biological phenomena including voltage-activation of a sensory membrane protein, metabolite transport across a bilayer, membrane protein folding, stress-induced phase separation, and properties of disordered proteins, both soluble and membrane bound. To address these topics in depth, we are expanding the applicability of hydrogen exchange techniques to membrane proteins under an activating voltage, during their folding, and even in vivo to examine their dynamics in cells. Our Upside simulation algorithm is powerful and enhances each of the experimental projects.